Variable brain oxycodone metabolism alters drug effect

7. Project Summary/Abstract
Opioid drugs are effective pain-relievers that elicit analgesia through their action at brain µ-opioid receptors,
simultaneously activating rewarding brain pathways, which can lead to opioid tolerance and drug dependence.
The U.S. has the highest world-wide per capita use of opioids creating enormous health and societal costs
related to addiction and treatment, lost productivity, and increased crime. Response to opioid drugs varies
widely between people, and potentially between genders, but it is not clear why people experience different
levels of pain relief from the same opioid, and why some people progress to become addicted. Many opioids
are activated to even more potent µ-opioid receptor agonists by CYP2D enzymes, such as oxycodone that is
converted to oxymorphone. However, oxymorphone is transported out of the brain and body more rapidly than
oxycodone, hence oxycodone is responsible for analgesia. This project uses unique research methods to
investigate how metabolism of opioids by CYP2D enzymes in the brain is important in oxycodone, tramadol
and hydrocodone response. Both liver and brain CYP2D levels are regulated by genetics, but in addition, brain
CYP2D is very sensitive to environmental chemicals, notably nicotine. Therefore, there can be two individuals
who have the same CYP2D activity in the liver (same genetics) but very different levels of CYP2D activity in
the brain, e.g. through smoking. Their drug and metabolite blood levels may be similar, but metabolism by
brain CYP2D can alter oxycodone levels in the brain, influencing pain relief, tolerance and abuse liability.
“How does variation in oxycodone metabolism by CYP2D in the brain affect oxycodone analgesia and
reward?” Validated rat models of analgesia, tolerance and reward, will be used with drug and dopamine
microdialysis, pharmacokinetic modelling, and established methods of manipulating brain but not liver CYP2D
levels. Brain CYP2D will be reduced by injecting chemical inhibitors into the brain, and increased by chronic
systemic nicotine treatment. Decreased brain CYP2D should increase analgesia, tolerance and reward through
reduced oxycodone conversion to oxymorphone, resulting in higher brain oxycodone levels. Increased brain
CYP2D should decrease analgesia, tolerance and reward through greater metabolism of oxycodone to
oxymorphone, resulting in lower brain oxycodone levels. Plasma oxycodone and metabolites levels will not
change as liver CYP2D is unaffected by these manipulations. Two additional CYP2D substrates, the commonly
prescribed oral opioids, hydrocodone and tramadol, and sex differences in oxycodone responses will also be
investigated. This will improve mechanistic understanding of this novel source of variation between people in
their opioid response, and identification of individuals at risk for opioid pain-treatment failure and progression to
dependence on these widely used oral opioids. Extensive PB-PK modelling will assist in extrapolations to
human, as will planned human PET imaging studies. The knowledge acquired from this project will contribute
to our on-going efforts to reduce the societal and health costs of opioid drug misuse and dependence.

Public health relevance
8. Project Narrative The U.S. is the world’s highest per capita user of opioids, and rates of dependence, emergency department visits and overdose deaths are rising, particularly among women. This project investigates a unique source of variability among individuals that alters opioid analgesia and abuse, namely how the brain differs in its ability to metabolize opioids, altering the drug response. This provides information on an entirely new mechanism for variation between people which may aid in identifying those at higher risk of both analgesic treatment failure and abuse of opioid drugs.